Bridge Funding - Genetic variant-based drug discovery targeting conserved pathways of aging

PROJECT SUMMARY/ABSTRACT (ADMINISTRATIVE SUPPLEMENT)
Aging is the most important risk factor for common human diseases, such as diabetes, cardiovascular
disease, and cancer. Hence, targeting basic mechanisms of aging rather than individual diseases is a rational
strategy to develop treatments of age-related multi-morbidity. To test the validity of this approach
investigators in this U19 leverage the human centenarian resource at the Albert Einstein College of Medicine
to identify rare genetic variants associated with extreme human longevity to identify potential drug targets for
promoting healthy aging. Using resequencing data of 400 candidate genes in 450 centenarians and 550
controls we identified, in the previous funding period, rare, functional genetic variants and associated
pathways enriched in centenarians and potentially important for healthy longevity, including IGF-1, SIRT6,
FOXO3A, NF-kB and SMAD3. Importantly, analysis of new, whole exome sequences of 555 centenarians
and 508 controls, provided additional candidate variants, e.g., BLM, USP35, UBE3C. A number of the rare
variant candidates were further characterized and evaluated functionally in human ES cells and differentiated
lineages. We also generated mouse models of some of the variants for analysis of phenotypes relevant for
late-life human health and subsequently used the ES cell and mouse model results as leads for developing
assays and testing small molecules targeting the pathways affected by these rare variants. Interestingly,
many of the rare variants and/or affected pathways could be linked to the DNA damage response, including
cellular senescence. Based on the demonstrated success of our approach we now have expanded our whole
exome-sequenced cohort to increase robustness of the analysis, identify additional variants and study
candidate pathways through RNA-seq, functionalize additional candidate variants in ESCs and generate
more mouse models. This should allow us to greatly extend the number of validated therapeutic targets for
drug development.

Public health relevance
PROJECT NARRATIVE (U19 BRIDGE FUNDING) Aging is an important risk factor for most common human diseases, including type 2 diabetes, cardiovascular disease, cancer and neurodegeneration. Here we propose to test a new approach for developing therapies for these diseases. Rather than focusing on individual diseases, we will focus on the genetic differences between successfully aged, healthy centenarians and control individuals with no family history of extreme longevity. Based on our own preliminary results, many of such genetic differences involve physiological processes that have previously been shown to be involved in extreme longevity of model organisms. Using extensive genetic resources, including some from our pharmaceutical partner, Regeneron, here we will discover novel genetic variants that may be involved in healthy aging and longevity. We then will validate these genetic human variants in mouse models to confirm that the identified genetic differences truly affect aging and its various disease- related symptoms. We also propose to develop drugs that target either these rare variants or their pathways that could be used for extending human healthspan. This gene to drugs collaborative project will be the first to use the genetics of rare individuals with healthy aging to identify therapeutic approaches for targeting aging itself rather than its composite diseases for preventing, delaying onset and progression, and possibly even reverting many of the multiple age-related diseases.